Role of Adult Neurogenesis in Spatial Information Encoding in the Dentate Gyrus

Project Summary
The dentate gyrus (DG) is one of the few mammalian brain regions that continue to add new neurons through
adulthood. Adult neurogenesis is thought to confer advantages by improving spatial and context memory
discrimination: loss of neurogenesis impairs the ability to discriminate between similar but distinct places while
enhancing rates of neurogenesis improves this ability. Adult-born neurons, during a critical time in their
maturation when they have enhanced excitability and plasticity, are thought to improve the precision of neural
coding in the DG by making spatial representations more distinct. However, it is not yet known how adult-born
neurons affect the activity of the DG during behavior, as in vivo recordings in this area have only recently become
possible. We hypothesize that adult neurogenesis improves spatial memory by increasing the spatial information
encoded by the DG, via local feedback networks. To test this hypothesis we will use 2-photon microscopy to
image DG neural activity in vivo in behaving mice with manipulations of neurogenesis. We aim to: 1) Determine
if depletion of adult neurogenesis or silencing of new neurons decreases the encoding of spatial information in
the DG. 2) Determine if enhancing rates of adult neurogenesis is sufficient to increase spatial information in the
DG and whether the activity of new neurons is required for these changes, and 3) determine whether
hippocampal mossy cells, which receive inputs from DG granule cells, may be a critical circuit component in the
mediation of neurogenesis-dependent changes to DG spatial information. From these experiments, we will gain
essential knowledge of the processes through which adult neurogenesis contributes to spatial memory.

Public health relevance
Project Narrative The hippocampus is one of the few areas of the brain that integrate new neurons through adulthood. Adult- born neurons are known to improve spatial memory through processes that are not entirely understood. Here, we will test whether these neurons regulate the precision of brain circuits that encode spatial location. We expect to gain a better understanding of how adult neurogenesis improves cognition, which could open the door to potential new therapeutic targets for dementia and memory disorders.